Metalloenzyme Discovery and Pathway Engineering to Functionalizethe Inert C-H bonds of Amino Acids

Metalloenzymes serve in a myriad of critical biological processes. Notably, their ability to natively
functionalize inert C–H bonds with high regio- and stereoselectivity has garnered significant attention, as the
direct functionalization of chemical feedstock through C–H bond functionalization would serve as a streamlined
strategy for accessing desired compounds. This would circumvent many of the circuitous steps required in
synthetic chemistry (e.g. protection and deprotection of substrates and products), thereby also addressing some
of the chemical challenges associated with sustainability and green chemistry. Because the selective
functionalization of inactivated C–H bonds remains an outstanding challenge, the mechanisms that contribute to
the unique catalytic properties of metalloenzymes have been studied intensely, with the hope that the catalytic
prowess of metalloenzymes could be recapitulated in synthetic systems. However, the advances in molecular
biology, biochemistry, and protein engineering have facilitated a paradigm shift. While historically
metalloenzymes were limited to catalyzing their native reactions, certain enzyme families, such as such as
P450s, are now used to modify non-native substrates on the industrial scale. The early success in utilizing
metalloenzymes demonstrates their potential in addressing the current challenges with selectivity and
sustainability in synthetic chemistry and demonstrates the need to expand their scope in catalysis.
Amino acids are valuable precursors to accessing a wide array of chemically diverse, stereochemically-rich
compounds (e.g. therapeutic peptides, alkaloids, penicillins, polyketides, nonribosomal peptides). Given the
large number of aliphatic C–H bonds and multiple reactive functional groups present in amino acids, the selective
functionalization of these bonds is challenging. Studying and developing new ways to functionalize amino acids
using metalloenzymes therefore could provide new avenues to vastly expand the chemical space available to
construct new molecules and/or derivatize existing ones.
The work described in this proposal aims to study how to functionalize amino acids using metalloenzymes.
The first specific aim will focus on the discovery of new reactions catalyzed by understudied metalloenzyme
families. Enzyme discovery will be streamlined by finding sequences that colocalize with genes annotated to
work on free amino acids, thus limiting the potential substrate scope to canonical amino acids. The second
specific aim will focus on engineering reaction pathways by incorporating the chemistry non-heme Fe
halogenases. The Chang lab has discovered halogenases that halogenate the aliphatic positions of free L-lysine
and L-ornithine. Functionalization of these amino acids provides an avenue for generating valuable functionalized
N-heterocycles that could be used for drug discovery and/or modifying existing drug scaffolds. Altogether, the
proposed work will contribute to expanding the utility of metalloenzymes to address the challenges associated
with installing highly desirable chemical motifs selectively.

Public health relevance
Metalloenzymes are notable for their ability to functionalize inert C–H bonds with high regio- and stereoselectivity, and owing to recent scientific advances, they now serve as promising candidates for catalyzing reactions on the industrial scale. However, for their widespread adoption, it is essential to further expand their sequence and reaction space. The proposed research will address this by studying the functionalization of inert C–H bonds in amino acids, which could provide the starting point for their rapid diversification into bioactive small molecules.